Mechanisms of Prion Aggregation

Prion diseases are relentlessly progressive neurodegenerative disorders with death often within six months of
the onset of neurologic symptoms. Pathologic features include widespread extracellular prion aggregates,
spongiform degeneration, synaptic and neuronal loss, and severe astrogliosis and microgliosis. The structural
determinants of the prion protein (PrP) and endogenous co-factors that drive aggregation, govern prion
assembly, and impact aggregate spread through the central nervous system are unclear. A major goal of this
application is to define when and how the endogenous co-factor, heparan sulfate (HS), promotes fibril assembly
in the parenchyma and blood vessels and slows PrP clearance through the interstitial fluid using in vitro and in
vivo model systems. We have previously pursued a range of approaches using cell-based prion conversion
assays and newly generated transgenic and knock-in mouse models in collaboration with structural biologists to
define the mechanisms that underlie PrP self-assembly and species barriers to prion conversion. We discovered
using knock-in mouse models that N-linked glycans on PrP reduce spongiform degeneration, hinder plaque
formation, and repel HS binding. Further, we found that plaque-forming prions were composed of poorly
glycosylated, GPI-anchorless PrP bound to highly sulfated HS, underscoring the pivotal role of PrP post-
translational modifications in driving the aggregate conformation and disease phenotype. We also found that
reducing HS chain length decreases parenchymal plaque formation and prolongs survival. Finally, we identified
highly amyloidogenic segments in the PrP sequence that control cross species prion conversion, as the number
and location of glutamine and asparagine residues in PrP raise or lower the prion transmission barrier. In this
renewal, we aim to determine the PrP-HS interactions that promote prion aggregate assembly and accelerate
disease. We build on our long-standing observation that structural features of PrP, together with host
glycosaminoglycans, drive efficient prion conversion. First, we will genetically manipulate neuronal, astrocytic,
and endothelial HS chains and determine the impact on prion cell targets and survival using mouse models.
Second, we will define how endogenous HS regulates PrP clearance through the interstitial fluid using conditional
HS mouse models and radiolabeled PrP. Third, we will test the efficacy of antisense oligonucleotides (ASOs)
targeting HS biosynthetic enzymes or Prnp mRNA in the early and mid-stages of prion plaque development in a
prion disease model. We expect these mechanistic studies will (i) define how an endogenous co-factor, HS,
accelerates and modifies prion disease, and (ii) determine whether reducing PrP interactions with this potential
therapeutic target blocks prion spread.

Public health relevance
Prion diseases are rapidly progressive, fatal neurodegenerative disorders caused by aggregated prion protein. We have found that shortening extracellular glycosaminoglycans (GAGs) in the brain can enhance prion clearance and prolong survival. The proposed studies are expected to reveal mechanisms underlying how prions form plaques in the brain parenchyma and vasculature as well as test strategies to promote clearance, towards a goal of reducing plaque burden and slowing disease.